Integrated Treatment for Co-Occurring Opioid Use Disorder and Posttraumatic Stress Disorder

PROJECT SUMMARY/ABSTRACT
The objective of this K23 administrative supplement is to request support following the impending critical life
event of childbirth. I was awarded this NIDA K23 in August 2022. During the first three years of this award, I
hired and trained research assistants and graduate-level study therapists. However, given budgetary constraints,
I am only able to pay for 8 hours a week of my current research assistant’s time, which is exclusively focused on
recruitment and completing baseline visits to assess eligibility in our ongoing randomized clinical trial. The K23
project had the following specific aims: In Aim 1, we modified the existing trauma-focused integrated
psychotherapy intervention to individuals with co-occurring opioid use disorder and posttraumatic stress disorder
(OUD/PTSD) using mixed methods feedback from interviews with provider and patients. In Aim 2, we conducted
an open-label trial to assess feasibility and further refine the treatment protocol among six eligible individuals. In
Aim 3, we are actively testing the new intervention—Helping Opioid Use Disorder and PTSD with Exposure
[HOPE]—combined with medications for OUD (MOUD) versus a MOUD-only control group in a randomized
clinical trial among 76 individuals with OUD/PTSD to evaluate feasibility and preliminary efficacy in reducing
opioid use and PTSD severity. During Aim 3, both groups are also completing ecological momentary
assessments to assess for daily opioid use, craving, and PTSD symptoms. I have made significant progress on
my K23 project, including completing the first two specific aims; submitting findings from both aims for peer-
reviewed publication; completing relevant trainings, fellowships, and didactics; and publishing 16 co-authored
manuscripts since the receipt of this award. Moreover, I have launched the randomized clinical trial and have
enrolled 2 out of the 76 participants. Despite my progress on my K23 goals, study progress will be significantly
interrupted by my upcoming parental leave. Therefore, the purpose of this K23 administrative supplement is to
request funding for me to hire full-time personnel to assist with the execution of the project in addition to cover
the effort of faculty investigators who may manage the clinical trial and clinically supervise study therapists and
patients actively enrolled in the trial while I’m on leave. The research assistant and faculty supervisors will assist
with my current duties on my K23 and will oversee active patients, supervise study therapists, and enroll new
patients into the study. In addition, these individuals will assist with data management and cleaning so that I will
be on track to submit my first R01 application as contact PI in the next year. Upon the completion of my parental
leave, I will return to full productivity and execute the study aims with the long-term goal of becoming an
independent investigator in the field of addiction science and co-occurring mental health conditions.

Public health relevance
PROJECT NARRATIVE The purpose of this K23 administrative supplement is to request funding to hire support personnel following the impending critical life event of childbirth. The support of a full-time research assistant, a clinical supervisor for the ongoing randomized clinical trial, and a faculty investigator to oversee the execution of the project will significantly assist the project by (a) subsuming duties I am executing now, (b) maintaining progress for my proposed project timeline, (c) supervising active patients and study therapists in the clinical trial, and (d) continuing to advance data management and cleaning for future analyses. Potential support from this supplement will directly advance my long-term career goal to be an independent investigator by facilitating the submission of subsequent R01s as principal investigator.